New Insights into the Federal Calorie Labeling Law

Project Summary/Abstract
Consumption of “away-from-home” or prepared foods is rising and contributes to poor diet, obesity and
related health problems. Prepared foods include “ready-to-eat” food purchased outside the home at
restaurants and other retail food stores. While most prepared foods are sold in restaurants, increasingly,
supermarkets and other similar food retailers are offering these products. By April/May 2017, most chain food
retailers in the United States began posting calories on restaurant menus and on prepared foods. These
retailers did so in anticipation of coming federal regulations that will require calorie labeling. The regulations
were initially set for implementation in May 2017 but were delayed until May 2018; by this date, all chain food
retailers with 20 or more sites across the US will be required to label. This grant proposal will be the most
comprehensive and objective examination of calorie labeling to date, covering different settings (fast-food
restaurants, supermarkets) and potential effects of labeling (customer purchases, reformulation of food items,
health outcomes, altered social norms). Conducted in partnership with a large fast-food chain franchisee in
the South and a large supermarket chain in the Northeastern United States, we will examine transaction
records from 93 fast-food restaurants and 194 supermarkets to determine whether calories purchased from
prepared foods change after labeling. The research team also will track the nutrition characteristics of items
sold at the largest US restaurant chains and at a supermarket chain to determine whether the food industry
introduces new lower-calorie products after labeling or reformulates existing products to be lower calorie. We
will incorporate all of these results on changes after labeling into a model that will predict whether obesity
rates also change after labeling. Further, by examining mentions, searches and sentiment regarding calories,
labeling, and food establishments on the internet and social media platforms, this study will have an
unprecedented opportunity to determine whether calorie labeling has a broader societal effect, beyond
purchasing and health outcomes. To date, all calorie labeling research has been conducted in restaurants,
cafeterias, or lab settings. This study will be the one of the few to examine comprehensive transaction records
from food retailers, the first to evaluate the effect of calorie labeling on supermarket prepared foods, and the
first to examine the impact of a federal nutrition policy on internet and social media discussions regarding
calories and labeling. Funding this research will lay the foundation for a number of exciting future research
opportunities. This project will lead to the creation of a large dataset of transactions over time from
restaurants and supermarkets and data from internet and social media platforms that could be used for
evaluation of future policies, such as the US Food and Drug Administration’s forthcoming changes to the
Nutrition Facts label. The partnership with a large fast-food chain franchisee and a large supermarket chain
also may lead to real-world experiments of strategies to augment calorie labeling. This project will provide
important answers to policymakers, industry leaders, and public health professionals about whether and how
calorie labeling works.

Public health relevance
Project Narrative This study will investigate the effect of the federal calorie labeling policy on food purchased at fast-food restaurants, prepared foods purchased at a supermarket chain, food industry reformulation of products, obesity rates and cost effectiveness, and mentions and sentiment regarding calories and labeling on the internet and social media. This study will be the most comprehensive examination of calorie labeling to date, across multiple settings and outcomes.